GLP-1 Receptor Agonists to Decrease Ethanol and CVD Risk in HIV (GL1DER HIV RCT)

Unhealthy alcohol consumption and cigarette smoking are leading causes of cardiovascular disease (CVD)
and death, often co-occur, and are common among people with HIV (PWH) who bear a two-fold excess risk of
CVD compared to people without HIV. Further, PWH experience higher mortality at lower levels of alcohol
consumption than people without HIV. Alcohol use, smoking, and HIV each independently elevate systemic
inflammation and undermine cardiometabolic health via myriad pathways including dyslipidemia and increased
visceral adiposity. While modestly effective therapies exist for smoking, few exist for alcohol use, and more
effective therapies for alcohol consumption and smoking are urgently needed to reduce CVD risk and mortality
among PWH. Glucagon-like peptide receptor agonists (GLP-1 RA) reduce insulin resistance and inflammation,
promote weight loss, and prevent CVD in patients with and without diabetes, setting a new standard of care to
improve cardiometabolic health in people at high risk of CVD. GLP-1 is produced in the gut and brainstem and
GLP-1 receptors throughout brain regions underlie reward and motivation (e.g., ventral tegmental area,
nucleus accumbens, medial habenula). In preclinical studies, GLP-1 RA attenuate rewarding effects of alcohol
and nicotine and reduce consumption of these substances. Early clinical trials report that GLP-1 RA lower
alcohol craving and consumption, promote smoking abstinence, and blunt weight gain after abstinence. There
is a strong scientific premise to study GLP-1 RA for alcohol use, smoking, and CVD risk, but no trials have
tested these outcomes in PWH. To address this critical gap, we propose the GLP-1 Receptor Agonists to
Decrease Ethanol and CVD Risk in HIV (GL1DER HIV) RCT, a double-masked placebo-controlled RCT to
assess efficacy of the potent oral GLP-1 RA semaglutide for 12 weeks among 200 PWH who drink alcohol,
most of whom also smoke. We will conduct GL1DER within the Tennessee Center For AIDS Research and
recruit from the Vanderbilt University Medical Center Comprehensive Care Clinic, the largest HIV clinic in the
Southeastern U.S. Our team has conducted RCTs using pharmacotherapy to treat alcohol use and smoking
among PWH, as well as RCTs of GLP-1 RA in patients without HIV. Our Specific Aims will test the efficacy of
oral semaglutide compared to placebo for (Aim 1): alcohol consumption (primary study outcome), craving, and
abstinence; (Aim 2) cigarette smoking, craving, and abstinence; and (Aim 3): CVD risk outcomes including
biomarkers of inflammation and gut permeability, body mass index (BMI), Reynolds (CVD) Risk Score, and the
VACS (mortality) risk index. We hypothesize that participants allocated to semaglutide will have significantly:
(Aim 1) lower alcohol consumption and craving and higher abstinence; (Aim 2) lower smoking rate, craving,
and higher abstinence; and (Aim 3) lower CVD risk (e.g., biomarkers of inflammation, BMI, CVD risk score).
IMPACT: GLP-1 RA could be paradigm-shifting for PWH through a “1 drug, 3 conditions” approach that
simultaneously addresses alcohol consumption, smoking, and CVD risk.